Optimizing telehealth across the cancer care continuum during the COVID-19 national emergency

Our experience with telehealth proved essential for current coping with the COVID-19 crisis, in that we were able to rapidly scale our activities. The result of these ramp up activities was of high impact—not only were we able to limit exposure of vulnerable cancer patients to COVID by keeping them out of the clinics, but we were able to reduce patient density (and therefore exposure) for all patients undergoing active treatment. Moreover, telehealth is also being used to ensure that any cancer clinical trial deemed essential by a care provider and all cancer trials with curative intent remain open at SKCC. At present, telehealth is being used for 3 major purposes: 1) pre-visit consultations to discuss care plans, given limits on visitors and caregivers in the clinic; 2) follow-up visits for all suitable patients, especially wherein lab testing and imaging can be completed off site and 3) visits with oncologist-social worker teams, given the high anxiety associated with cancer care in the backdrop of the COVID crisis. Given the natural experiment that resulted in increased telehealth use in cancer care delivery due to the COVID-19 emergency, it is our hypothesis that telehealth enhances the quality of oncology care by improving patient outcomes.

Public health relevance
Project Narrative The overarching goal of the Sidney Kimmel Cancer Center (SKCC) is to leverage research expertise to reduce the overall incidence, burden, and mortality from cancer in Greater Philadelphia and beyond. SKCC goals are realized through unique strengths in addressing cancer problems through collaboration across basic, clinical, and population research disciplines. SKCC is nucleated at Thomas Jefferson University (TJU) and enriched by fully integrated research consortium partners from Drexel University (DU)'s School of Medicine and School of Public Health and the Lankenau Institute for Medical Research (LIMR); building on these strengths, SKCC focuses on addressing catchment area needs through nurturing transdisciplinary research, expanding innovative research capabilities, extending outreach and clinical research into the community, and enhancing the pace of bench-to-bedside discovery.